EVALUATION OF EFFECT OF DEXAMETHASONE ON SYNOVIAL FLUID IN RHEUMATOID ARTHRITIS

To compare the effects of dexamethasone with that of placebo on the kinetics of gadolinium movement into the synovial fluid space of a swollen knee using magnetic resonance imaging.